PHENYLBUTYRATE &MUCOCILIARY CLEARANCE IN CYSTIC FIBROSIS

This is a randomized, placebo-controlled, double blind crossover trial in 10CF patients of the effects of phynylbutyrate on pulmonary mucociliary clearance (MCC). The aim is to quantify and compare the rate of MCC on study drug and placebo. Patients will take a standard dose three times a day for one month separated by a month of washout. Radiotracer MCC, nasal potential differences, and sweat chlorides will be measured.